HIV Pharmacology Data Repository

Abstract
HIV Pharmacology Data Repository (HIV PDR)
Clinical pharmacology is paramount to developing new therapeutic strategies for HIV treatment, prevention, and
cure that are needed to end the epidemic. Since its inception in 2001, the UNC Center for AIDS Research
(CFAR) Clinical Pharmacology and Analytical Chemistry (CPAC) Core has led the field in the provision of high-
quality clinical pharmacology services to HIV/AIDS researchers. The CPAC Core has consolidated >75,000
unique concentration vs time (CvT) datapoints resulting from >29,000 samples collected across 482 unique
studies quantifying 72 drug molecules in 10 species and 14 anatomical compartments into a single searchable
data portal - the HIV Pharmacology Data Repository (HIV PDR). Pooled CvT data can be easily extracted
from the HIV PDR in machine readable output, making this data portal a valuable informatic tool for sharing and
exploring antiretroviral pharmacokinetic data to accelerate biomedical research discovery. We seek to maximize
the HIV PDR’s scientific impact by expanding and disseminating this resource through the following aims: 1)
creating new tools to catalyze data expansion, 2) demonstrating utility by promoting scientific exploration, and
3) propagating use by engaging users and characterizing their Target Product Profile (TPP). To this end we
propose to apply FAIR (Findable, Accessible, Interoperable, Reusable) principles to expand CvT data archives,
promote exploration, and empirically inform downstream development of the HIV PDR. We will ensure the long-
term sustainability of this valuable resource by creating advisory boards to oversee the development of a robust
governance plan designed to ensure regulatory compliance while meeting user needs. Finally, in performing the
proposed aims, we will pioneer a data-sharing service to assist HIV/AIDS researchers in meeting the
recommendations provided within the 2023 NIH Policy for Data Management and Sharing.

Public health relevance
Project Narrative New HIV treatment, prevention and cure strategies are needed to end the epidemic. Sharing scientific data will accelerate their discovery. We will transform an HIV pharmacology database into a widely used, data-sharing service by expanding data archives, promoting scientific exploration, and characterizing user preferences.